Neuroimaging Core

PROJECT SUMMARY– NEUROIMAGING CORE
Neuroimaging Core will support the Mayo Clinic ADRC with standardized operating procedures for
neuroimaging in Mayo Clinic Rochester (MCR) and Mayo Clinic Florida (MCF) and promote the
applications of advanced imaging technology in the Alzheimer’s disease (AD) and AD-related dementias
(AD/ADRD) for the evaluation of multiple etiology dementia. The goal of the Neuroimaging Core is to
provide imaging biomarker data for diagnostic classification and staging of AD/ADRD, for research projects
and clinical trials on ADRC participants through a harmonized multimodality neuroimaging program at the
MCR and MCF sites, designed to support the overarching theme of the ADRC: “Multiple Etiology
Dementias.” The Neuroimaging Core will provide innovative technology and resources for understanding
the pathologic processes contributing to neurodegeneration and cognitive impairment through multimodal
imaging, for individualized imaging biomarker-based diagnosis considering sex as a biological variable,
ethnicity, race, additional structural and social determinants of health, and genetic-risk. The aims of the
Neuroimaging Core include: 1) Establish and maintain a harmonized MRI, DaTscan SPECT, β-amyloid,
tau, and FDG PET imaging program for Mayo Clinic ADRC MCR and MCF sites, and operate a
standardized quality control, image processing, and data analysis program for the ADRC cohorts including
the African American/Black and Hispanic/Latino Cohorts in MCF; 2) Support imaging studies, share ATN
and other imaging biomarker data on multiple dementia etiologies (AD, Lewy bodies, vascular) with the
ADRC Data Core, affiliated research projects and clinical trials, and the National Alzheimer’s Coordinating
Center (NACC), while protecting patient confidentiality when sharing high-resolution images using novel
defacing approaches; 3) Provide leadership and education in neuroimaging within the ADRC research
community and support development, utilization, and sharing of neuroimaging biomarkers in AD/ADRD.
Neuroimaging Core will collaborate with the Clinical Core and the Outreach, Recruitment and
Engagement (ORE) Core on recruitment of clinically characterized rural dwelling, Hispanic/Latino and
African American/Black participants to imaging studies, with the Biomarker Core for correlating the fluid
biomarkers with the imaging findings, with the Neuropathology Core for autopsy confirmation of imaging
findings associated with multiple etiologies, with the Data Management and Statistical Core to share
imaging biomarker data with the Genomics Core and Digital Innovation Core, and with the Research
Education Component (REC) on training early-stage investigators on imaging biomarkers.